Soluble αSyn is a modulator of AD pathophysiology

Project Summary Despite immense efforts, the mechanisms underlying Alzheimer’s disease (AD) are not well understood. Exploiting transgenic mouse models of AD as well as cell culture models, which we established in the current funding period, we now propose a collaborative effort built on two interrelated directions, each designed to uncover the molecular mechanisms allowing alpha-synuclein to influence AD pathology and AD-associated synaptic and cognitive deficits. We will first test whether temporal regulation of SNCA, the gene encoding alpha- synuclein (αSyn), in adult mice attenuates central components of the phenotype of AD mouse models. We will test the hypotheses that αSyn stalls the conversion of prefibrillar amyloid-β (Aβ) assemblies into fibrils thereby exacerbating synaptic injury. If successful, these studies will define the role of αSyn as an important modulator of AD pathology and AD-associated deficits and will establish a proof-of-principle to support testing therapeutic strategies that target αSyn in the context of AD.

Public health relevance
Project Narrative A central question in Alzheimer’s disease (AD) is how synapse loss occurs and whether (and if so, how) synaptic and memory loss can be attenuated or halted. This effort seeks to uncover how alpha-synuclein contributes to Aβ pathology and Aβ-induced defects, and whether transient reduction of the SNCA gene encoding for αSyn alleviates synaptic and cognitive deficits in mice.